Proteomic profiling for proteins associated with intracranial atherosclerotic disease.

PROJECT SUMMARY/ABSTRACT
Dr. Qing Hao is a vascular neurologist whose research focused on understanding the pathophysiology of
intracranial atherosclerotic disease (ICAD) and risk stratification in ischemic stroke using a multimodal approach
(neuroimaging and laboratory biomarkers), with the ultimate goal of investigating more efficacious stroke
prevention strategies to improve clinical outcomes. The proposed training and mentored research will address
critical gaps in her knowledge and research skills, and provide her with the foundation necessary to become a
successful, independent clinical investigator in the field of cerebrovascular disease. Her training objectives are:
1) To master skills in applying proteomic approaches to patient-oriented clinical research; 2) To develop skills to
independently integrate and analyze large-scale, complex, multimodal datasets; 3) To learn how to effectively
conduct and lead collaborative clinical research projects, and progress toward an independent investigator.
These training objectives will be achieved through carefully selected, highly relevant formal coursework,
attendance at conferences, workshops, hands-on training on study design and management, data analysis, as
well as guidance from her mentoring team. The proposed research project will to investigate the proteomic profile
of ICAD in order to identify novel biomarkers associated with ICAD occurrence and ICAD plaque activity. Dr.
Hao will first identify the proteins by direct tissue proteomics based on intracranial arterial samples, aiming to
discover proteins and pathophysiological mechanisms that are highly specific to ICAD. Then she will examine
the proteins from peripheral blood samples in ICAD subjects without stroke to identify proteins associated with
ICAD occurrence, and in symptomatic ICAD subjects with acute stroke to identify proteins associated with active
ICAD with high risk of causing clinical events. The findings from this K23 will enhance our understanding of the
pathophysiological mechanism of ICAD, diagnosis and risk stratification, and ultimately enable novel therapeutic
targets to minimize the risk of stoke recurrence and adverse outcome related to ICAD. The Icahn School of
Medicine at Mount Sinai provides the ideal environment for Dr. Hao’s training and research needs, as she has
assembled a team of mentors and collaborators who are internationally recognized experts in their fields and
have incredibly strong mentorship track records. Her mentors and co-mentors are Dr. Bin Zhang (genomic and
proteomic research), Dr. Rebecca Gottesman (cerebrovascular disease & clinical research), and Dr. Junmin
Peng (multi-omics in biomedical research). Other faculty in the mentoring committee will offer distinct and
complementary advices in area of proteomic research methodology, large scale data analysis and skills of
leading a multidisciplinary research program. This comprehensive training approach afforded by K23 award will
enable Dr. Hao to acquire essential knowledge and skills to implement the research, and to become a respected
clinical investigator and leader in cerebral atherosclerotic disease and stroke.

Public health relevance
PROJECT NARRATIVE As one of the major causes of ischemic stroke worldwide, intracranial atherosclerotic disease (ICAD) is associated with high risk of stroke recurrence, and there are no reliable blood biomarkers to help diagnose ICAD or predict the future stroke risks. This study will explore novel biomarkers for ICAD using the proteomic approach to identify proteins that are associated with ICAD occurrence and ICAD plaque activity, based on the intracranial plaque tissue and peripheral blood samples. Our findings will lead to a better understanding of the disease mechanisms, diagnosis and risk stratification, and ultimately enable novel therapeutic targets to minimize the risk of stoke recurrence and adverse outcome related to ICAD.